MECHANICALLY ROBUST 3D-PRINTED MICROCAPILLARY NEEDLES WITH ANTI-CLOGGING CAPABILITIES

PROJECT SUMMARY
Biomedical applications in both research and clinical settings rely on microinjection protocols that require using
a hollow microcapillary needle to deliver foreign substances (e.g., nucleic acids, proteins, viruses, cells, and
nanoparticles) directly into biological targets (e.g., cells, embryos, and tissues). This transgenic engineering
technique has driven advances in fundamental research in areas including cell, systems, and developmental
biology, stem cell gene manipulation, and human disease prevention modeling, as well as for medical
applications including in vitro fertilization (IVF) cycle therapy, pre-implantation genetic diagnosis, and
intraocular injection. However, the industry standard microneedles (ISNs) used for microinjection in research
settings are typically produced lab-by-lab by physically “pulling” apart transparent glass capillary tubes, which
results in needle variability. The inconsistencies can negatively affect experimental rigor, reproducibility,
productivity, and microinjection efficacy. Thus, the ability to enhance and expand the capabilities of the
microneedles that enable microinjection protocols could significantly impact diverse biomedical fields and
applications. We hypothesize that by leveraging well-established “pyrolysis” post-processing strategies for
enhancing the mechanical properties of DLW-printed 3D microstructures, we can achieve mechanically robust
microinjection needles—based on our pending-patented MSP design—that simultaneously address all the pain
points of ISNs. This proposal will systematically evaluate the utility of the mechanically robust 3D-printed
microcapillary needles versus ISNs with regard to key quantitative metrics of performance underlying material
delivery into zebrafish embryos by: 1) establishing and characterizing pyrolysis protocols for DLW-printed 3D
microneedles, 2) Interrogating the mechanical properties of pyrolyzed 3D microneedle prototypes in vitro, and
3) evaluating microinjection efficacy of pyrolyzed DLW-printed 3D microneedle prototypes versus ISNs using
live zebrafish embryos in vivo. These innovative, geometrically sophisticated, functionally advantageous
microneedle with robust mechanically properties hold unique promise to allow for fast, accurate, and consistent
microinjections with minimal damage to injection targets (e.g., embryos).

Public health relevance
PROJECT NARRATIVE Microinjection, which entails using a microcapillary needle to deliver foreign substances (e.g., e.g., nucleic acids, proteins, viruses, cells, and nanoparticles) into biological targets (e.g., cells, embryos, and tissues), is widely used for research and clinical applications ranging from animal-based genetic experimentation to fertility treatments, genetic diagnoses, and disease prevention modeling in humans. This proposal will evaluate the utility and performance of novel mechanically robust 3D-printed microcapillary needles compared to the current industry standard needles. This pending-patent direct laser writing design has the potential to simultaneously address customer pain points and bridge an important need in the microinjection industry.